CRCNS: A computational approach to map visual cortex organization in the human brain

PROJECT SUMMARY
About a quarter of the human cerebral cortex is visual, with dozens of retinotopic maps and
category selective regions. Localizing these areas is crucial to much of human visual
neuroscience research and to clinical care. Area localization, such as delineating the boundaries
of primary visual cortex, is a necessary step in studies that measure neural activity or anatomical
properties because knowledge can only be aggregated across labs, groups, studies, and the
lifespan if researchers can identify the same visual areas in each person. Moreover, brain area
boundaries often serve as dependent measures themselves, for instance in studies that track the
size of face or word-selective areas during development, or that link the surface area of a visual
map to performance–e.g., V1 and acuity or hV4 and recognition in clutter.
However, while dozens of functional visual areas have been identified on cortex, many are
technically difficult to localize, and few have been carefully characterized across large populations
of individuals. The field lacks validated computational methods to parcellate visual cortex into its
component retinotopic maps and category-selective regions at the level of individual subjects,
and it lacks a quantitative description of how anatomical map properties (size, tissue thickness,
myelination, white matter inputs, etc) vary across large populations. The central aim of this
proposal is to quantify how the components of the cortical visual system vary (and covary) in large
populations of human subjects. We take two complementary approaches. One is to develop
machine learning (ML) algorithms to delineate visual areas using various combinations of MRI
inputs. The other is to establish descriptive models of the distribution, heritability, and patterns of
co-variation of properties of visual cortical areas and their associated white matter tracts.
Currently, accurately identifying visual system components in individuals remains challenging,
hampering both scientific and clinical progress. The results of this project will greatly increase the
ability of basic scientists and clinicians to accurately identify visual areas in individual humans
and to quantify how individual variability impacts vision. This in turn furthers the neuroscientific
understanding of vision and empowers translational research into the cortical origins of human
visual disorders.

Public health relevance
PROJECT NARRATIVE Neuroscientists have made strides in understanding the visual cortex's organization, but accurately identifying its components in individuals remains challenging, hampering both scientific and clinical progress. Here, we develop machine learning tools to accurately delineate the multiple visual brain regions in individual human subjects and then model how these regions vary and covary across people. The results will greatly increase the ability of basic scientists and clinicians to study the many separate parts of the cortical visual system in humans, furthering neuroscientific understanding of vision and links between cortical organization and visual health.